Biospecimen and Pathology Core

ABSTRACT
The Roswell Park Ovarian Cancer SPORE Biospecimen & Pathology Core (BPC) combines a centralized
mechanism for expert tissue handling services and performance of tissue-based assays by highly qualified,
experienced personnel with a state-of-the-art integrated informatics infrastructure which provides tools for
tracking biospecimen collection, histopathological evaluation, and clinical annotation of samples with linkage to
immunogenomic and other translational data generated by the Individual Research Projects proposed in this
renewal application. The Core will collect, de-identify, process, bank, and distribute annotated, high-quality
tumor and blood samples from patients participating in SPORE-sponsored clinical studies. In addition, the BPC
will provide investigators with specialized technical and interpretative histopathology services including
expertise in multiplexed immunohistochemistry (IHC) and imaging mass cytometry (IMC), tissue microarray
construction, laser capture microdissection, digital imaging, and quantitative pathology review of slides, tumor-
infiltrating lymphocytes assessment, tissue QC/QA and preparation for next-gen sequencing-based assays
(whole exome seq, RNAseq, TCRseq, MethylSEQ), and oversight on optimal utilization of each biospecimen.
The Core will also be instrumental in testing patient biospecimens to determine eligibility for clinical trials and
directly add to the bi-directional translational science by a detailed immunological annotation of ovarian tumors.

Public health relevance
NARRATIVE The Biospecimen & Pathology Core is instrumental to the overall translational research objective of the Roswell Park Ovarian Cancer SPORE. The Core provides services related to biospecimen collection, processing, distribution and provision of specialized diagnostic and technical histopathology services to SPORE investigators.